Neuromodulatory system abnormalities in late life depression: Associations with mood, cognition, and motor frailty

Major Depressive Disorder in older adults, or Late life depression (LLD), is characterized by mood symptoms
and is also often further complicated by motor frailty and cognitive dysfunction. Additionally, LLD is also one of
the strongest identified risk factors for accelerated cognitive and functional decline. The factors contributing to
motor frailty and cognitive dysfunction in LLD are currently poorly understood which prevents the early
identification of individuals most at risk for poor outcomes. The combination of mood, frailty, and cognitive
disturbances in LLD implicates dysfunction within specific networks of monoamine- and cholinergic brainstem
and basal forebrain nuclei that together make up the neuromodulatory system. The widespread subcortical and
cortical projections of the neuromodulatory system control the brain’s activity state and thus behavioral
responses to incoming internal and external information. Of note, neuromodulatory system abnormalities are
often already present in the preclinical or very early stages of other neurodegenerative diseases before higher
order cortical and subcortical structures become affected. These abnormalities therefore have the potential not
only to become an early marker of LLD but also risk for poor outcomes. However, the neuromodulatory system
is a compex structure made up of densely packed and often not well-delineated fiber tracts and small nuclei
that are not discernible on conventional structural 3T MR and thus is understudies in LLD. New multi-contrast
based segmentation approach imaging processing methods have developed to address this challenge. The
goal of this project is to evaluate the association of depression severity, cognition, and motor frailty with
specific components of the neuromodulatory system and to demonstrate that structural and functional
abnormalities within this system are more strongly linked to baseline severity and longitudinal progression of
these symptoms than abnormalities within their higher cortical and subcortical target structures. Specifically, it
will be demonstrated that: 1) Structural and functional abnormalities within the dopaminergic and
serotoninergic brainstem and forebrain nuclei will be more strongly associated with depression severity than
their cortical and subcortical projection areas, 2) Abnormalities within the noradrenergic locus coeruleus as well
as the brainstem and forebrain nuclei connected to it will be more strongly associated with cognition than those
within their cortical and subcortical projection areas, and 3) Abnormalities within the brainstem and forebrain
motor system will be more strongly associated with motor frailty in LDD than abnormalities within the higher
motor centers. This goal will be accomplished in a longitudinal study over 24 months with 100 LLD and 50 age
and gender matched non-depressed participants (ND). All participants will undergo a standardized evaluation
of mood, cognition, and frailty and structural and functional imaging at 3T at baseline. Longitudinal evaluations
will include depression assessments at six month intervals and cognition and frailty assessments will be
conducted annually (months 12 and 24).

Public health relevance
Late life depression (LLD) is characterized by mood symptoms and is also often further complicated by motor frailty and cognitive dysfunction which are associated with poor treatment response and risk for dementia. The factors contributing to motor frailty and cognitive dysfunction are currently poorly understood in LLD but the combination of cognitive, motor and mood disturbances points to a dysfunction within a network of monoamine- and cholinergic brainstem and basal forebrain nuclei that together make up the neuromodulatory system whose widespread subcortical and cortical projections control the brain’s activity state and by extension its behavioral responses. The overall goal of this project is therefore to associate depression severity, cognitive function, and motor frailty with specific components of the neuromodulatory system and to demonstrate that structural and functional abnormalities within these components are more strongly associated with these outcomes at baseline and longitudinal follow-up than subcortical and cortical abnormalities which will inform the future development of new and more effective screening methods for individuals at risk for poor outcomes as well as interventions for cognitive decline and motor frailty in older adults.